Understanding B cell immunity in Merkel cell carcinoma

PROJECT ABSTRACT
Merkel cell carcinoma (MCC) is a rare, highly aggressive, neuroendocrine carcinoma of the skin. Notably,
approximately half of all MCC patients with advanced or metastatic disease respond to anti-PD1/PD-L1 as a
first-line immunotherapy treatment, making it one of the most responsive solid tumors to immune checkpoint
blockade (ICB). The initial response rate strongly suggests that immune system function is critical for recognizing
and attacking MCC cells and perhaps can be restored and activated. Another interesting feature of MCC is that
there are two distinct disease etiologies. In a majority of MCC tumors, there is clonal integration of Merkel cell
polyomavirus (MCPyV) and expression of the viral antigens small T antigen (ST) and a truncated large T antigen
(tLT) that drive oncogenesis. The nonviral subset of MCC (MCCN) is driven by UV damage and has a high
mutational burden. In polyomavirus-positive MCC (MCCP), the viral antigens allow investigation into the adaptive
immune response in a cancer setting. Indeed, studies have extensively characterized the CD8+ and CD4+ T
cells that recognize large T antigen peptides in MCCP. Some MCC studies indicate that the presence of
circulating and tumor infiltrating MCPyV specific T cells can improve overall survival. However, there is conflicting
data to support that overall survival and response to immunotherapy are strongly correlated to CD8+ T cell
infiltration. Therefore, other immune cells in the tumor microenvironment of MCC may be contributing to
an antitumor response either directly through effector functions or indirectly through modulating T cell
activity. Recently, tertiary lymphoid structures, whose formation is driven by the recruitment of B cells, were
identified in both MCCP and MCCN subtypes and were associated with a favorable prognostic outcome. Aside
from their documented presence in MCC tumors, the role of B cells in MCC is not well understood. Tumor-
infiltrating B cells (TIL-Bs) are an emerging area of interest in cancer immunology. TIL-Bs can have pleiotropic
roles in tumor immunity that affect overall survival and immunotherapy response in many cancer types. However,
what defines the pro or antitumor role of B cells in the tumor microenvironment may depend on which B cell
subsets are present, their frequency, and where they are localized in the tumor microenvironment. Given that
both subtypes of MCC are highly responsive to ICB and that immune activation is potent in MCC, I
hypothesize that TIL-Bs in the tumor microenvironment will have characteristics of antitumor immunity
and will have a direct antigen-specific response to drive antitumor immunity. I will investigate this
hypothesis with the following aims: 1) Determine the landscape of B cells in the tumor microenvironment of MCC
and 2) Characterize the antigen specific responses of B cells in MCC.

Public health relevance
PROJECT NARRATIVE Merkel cell carcinoma (MCC) is a rare, aggressive skin cancer highly responsive to immune checkpoint blockade, suggesting a strong antitumor immune response. However, the immune cells contributing to antitumor activity in the tumor microenvironment of MCC are not well understood. This proposal will investigate whether tumor- infiltrating B cells, which have recently shown robust antitumor activity in several different cancer types, have antitumor activity in MCC.